MULTIDISCIPLINARY TECHNICAL INFORMATION RESEARCH

The primary objective of this contract is to provide a variety of critical chemoprevention resource support functions as required by the Chemoprevention Investigational Studies Branch (CISB) of the National Cancer Institute. The Scope of Work is comprised of four separate tasks areas: 1) chemopreventive Agent Support, 2) Chemopreventive Investigational Studies Branch (CISB) Program Overview and Planning Support, 3) Strategy Development by Workshops on Chemoprevention and 4) Regulatory Technical Support Service.